Research Capacity Core

RCC Summary: The long-term goal of the Research Capacity Core (RCC) is to support, strengthen, and
expand biomedical and behavioral research projects at Florida A&M University (FAMU). Over the past three
decades, tremendous success has been achieved by FAMU RCMI Center through the active support of the
research infrastructure (RIC) component of the RCMI Program. FAMU researchers have relied on the RIC
services by using key instrumental analysis and research personnel to gather data used to write NIH
proposals, develop funded projects, publish in refereed and indexed scientific journals, and successfully
train graduate students. There is a critical need to invigorate these strategies in order to continue
strengthening the campus biomedical and behavioral research activities, especially under the current rapid
technological advancements. The focus of the FAMU RCMI U54 RCC will be on promoting innovative
technologies that support the proposed RCMI research projects, pilot projects, and other FAMU biomedical
and behavioral research initiatives that address health disparities experienced by racial and ethnic
minorities, the rural and urban poor, and other medically underserved populations. The RCC will provide
state-of-the-art multi-disciplinary facilities, including the following technologies A) Nuclear Magnetic
Resonance (NMR) and Mass Analysis Facility, B) Molecular Modeling Facility, C) High Throughput Screening
and Drug Design (HTS-DD) Facility D) Multi-Omics Resource (MOR) Facility (E) Proteomics and Cytokine (PC)
Facility F) Flow Cytometry/Imaging (FI) Facility and G) Artificial Intelligence (AI), Bioinformatics and Statistics
(ABS) Data Management Facility. Artificial Intelligence (AI) will be woven through all cores, applying the
massive biological and public health data now available to propel predictive drug discovery, and expedite
new discoveries in biomedical and behavioral research. The formation of an RCMI Committee is proposed
that will address all pertinent AI issues: providing directives on training modules, workshops, consultations,
and adopted deliberate and appropriate AI approaches. AI issues dealing with ethics, data privacy, risk
management and liability concerns will be carefully considered. Similarly, the RCC will also promote
leading edge scientific technology by providing workshops, seminars, and short courses in drug
discovery and biotechnology research applications to enhance research proficiency. The proposed RCC is
relevant to the NIH/NIMHD mission of developing the research infrastructure and training investigators to
be more successful in obtaining competitive extramural support in biomedical and behavioral research that
addresses minority health and health disparities.